ImmGen: Gene Expression and Regulation in Immune Cells

ImmGen is a collaborative group of 19 Immunology and Computational Biology laboratories who perform,
under standardized conditions, a thorough dissection of gene expression and its regulation in the immune
system of the mouse. Shared SOPs, data generation and processing pipelines have made for cross-
comparable gene expression and epigenetic data that serve as frequently consulted public resource and
reference. Machine learning approaches have been developed to infer underlying genetic regulatory networks.
These main themes will be continued: 1, Charting Transcriptomes. We will continue to evolve the ImmGen
gene expression compendium, combining population RNAseq with single-cell RNAseq/CITEseq to chart the
landscape of immunocytes across lymphoid and parenchymal organs, lineage co-adaptation to organismal
locations, infectious/autoimmune challenges, or genetic or sex-specific variation. We will expand the ongoing
catalog of cytokines signatures in all the major lineages. To chart the “dark transcriptome” (unrecognized
transcripts or splice variants missing from standard references), long-read direct RNA sequencing will be
applied, at baseline or after strong activation. 2, Charting Immunogenomic Regulatory Networks. We will
further ImmGen’s epigenomic charting: (i) ongoing highly granular mapping of the histone post-translational
modification code will be expanded to non-standard PTMs that reveal subtle aspects of the code’s
implementation; (ii) we will generate genomewide methylome profiles across lineages; (iii) multimodal
strategies that match chromatin accessibility and mRNA across single-cells (SHAREseq) will be applied in
“buckets” of cells of a given lineage (T, B, ILC, myeloid) that encompass the range of phenotypic variation
within a lineage, internally validated by using F1 intercross mice as donors, relating genetic variation in TF-
binding motifs with chromatin activation. These multilayered data will serve as input for ongoing Artificial
Intelligence decoding of regulatory networks underlying immunocyte differentiation. 3: From Data to Public
Reference. The role that ImmGen data serve as a community reference will be broadened. The interactive
databrowsers on the ImmGen web and smartphone app will be expanded and optimized (cell-type centered
querying, RNA-protein match). With the leitmotiv of reference data homogeneity, we will import and harmonize
a collection of multimodal immunogenomic datasets, complementing those produced internally. This
homogenous resource will be served for facilitated public browsing, and will support: (i) definitions of immune
cell-types based on statistically objective distance- and continuity-based criteria (ii) Reference Maps (cross-
organ or cross-lineages) for public use, against which new studies can be aligned by label transfer software,
with a dedicated online service (iii) panels of expression signatures identifying cell-types or co-regulated gene
modules. This reference work will solicit community feedback and participation via moderated electronic
forums. To enable facile computation and re-use, we will deploy cloud-based ImmGen data access (Terra).

Public health relevance
Through the high quality gene expression data it has generated, ImmGen has become an important resource in Immunology research. This next cycle of funding will expand the definition of gene expression across the immune system, analyze how its regulatory hierarchy relates to immune responses. It will thus provide an essential foundation for the immunogenic understanding of immune responses in health and disease.